Wyoming IDeA Networks for Biomedical Research Excellence Phase 4

PROJECT SUMMARY
The Wyoming IDeA Networks for Biomedical Research Excellence INBRE aims to establish a statewide network
for biomedical research and excellence. Specifically, WY INBRE aims are to: 1) build the multidisciplinary
research network with scientific foci that will strengthen biomedical research expertise and infrastructure at the
University of Wyoming and its partner institutions; 2) build the research base and capacity of the University of
Wyoming and its partner institutions by providing research support to faculty, postdoctoral fellows and graduate
students; 3) provide research opportunities for undergraduate students; 4) enhance the science and technology
knowledge of the state's workforce; and 5) expand Wyoming research opportunities across the Western IDeA
Region. Consistent with these goals, this Administrative Supplement (NOT-GM-23-034) aims to answer
significant multidisciplinary biomedical research questions using complementary, cutting-edge approaches. Our
team science approach will combine the expertise and diverse disciplinary perspectives of Dr. Nicole Bedford
(behavioral neuroscience), Dr. Danielle Bruns (cardiac aging), and Dr. Emily Schmitt (circadian biology).
Together, we will address a complex basic/translational research question using innovative technology. We aim
to understand the mechanisms of age-related nocturia, a condition with high morbidity in the aging population.
Specifically, we will dissect the 1) neurobehavioral and 2) cardiorenal circadian mechanisms of nocturia. Last,
we will 3) test the potential rescue of the nocturia phenotype by chronotimed exercise – a novel therapy with
significant translational potential. Successful accomplishment of this goal necessitates a team science effort.
Together, the proposal will not only address significant biomedical questions in aging populations, but our strong
collaborative team will generate preliminary data for extramural funding applications. The work proposed in this
supplement also includes the contributions of graduate and undergraduate research assistants, who are
necessary to expand biomedical research capacity in Wyoming.

Public health relevance
PROJECT NARRATIVE The goal of Wyoming INBRE is to promote the development, coordination, and sharing of research resources and expertise that will expand biomedical-related research and education opportunities and increase the number of competitive investigators in Wyoming. The current Administrative Supplement will support this goal through a collaborative team approach that will utilize innovative technologies to investigate fundamental biological mechanisms of nocturia with a focus on circadian biology and aging.